Cellular-level investigation of the reward circuitry controlling drinking

Project Summary
Thirsty animals quickly learn to drink fluids that rehydrate them. This reinforcement learning process is
necessary for the initial development of drinking behavior and the continual development of fluid preferences.
How this learning process works in the brain is not well understood, but likely involves dopamine-releasing
ventral tegmental (VTA DA) neurons. As I show in preliminary data, these VTA DA neurons strongly respond to
changes in blood osmolarity. I propose to examine how VTA DA projections transform fluid state changes into
behavioral reinforcement. This work will significantly further our understanding of the neural circuitry involved in
maintaining fluid balance. Additionally, homeostatic challenges demonstrate the physiological role of the
mesolimbic dopamine system, which is exploited by recreational drugs to promote addictive behavior. Finally,
this project will address the simple yet fundamental question of how the brain can transform an internal
sensation into behavioral reinforcement.

Public health relevance
Project narrative This project probes the role of mesolimbic circuitry in learned drinking behaviors. Doing so, this work takes a new approach to operant learning, focusing on how the brain integrates delayed internal signals (i.e. fluid state changes) to assign value to previous behavior (i.e. drinking). The findings from this project are additionally expected to elucidate the logic behind other motivated behaviors, such as feeding and drug seeking.